RISK, INSURANCE, AND THE FAMILY

DESCRIPTION (Adapted from the Applicant's Abstract): The purpose of the proposed research is to investigate the role of the family, inclusive of the extended family and networks of friends and relatives, in providing insurance and credit to its members, to understand and quantify that role in the larger village, regional, and national context, and to understand that role relative to that or more formal institutions, e.g., village level funds and national level banks. The specific investigation in Thailand takes advantage of recent and ongoing advances in economic theory and of substantial variation over region, the semi arid northeast versus the highly developed regions near Bangkok, and substantial variation over time, e.g., the high growth period and the recession and recovery of the Asian crisis. The idea is to study the family or extended networks as a collection of individuals gathered together into a "collective" organization which provides insurance and credit to its members, to understand the nature and boundaries of such collective organizations, and to understand the interaction of such collective organizations with each other directly, with other more formal institutions, and with the larger market. The family, community level institutions, formal national level institutions, and markets will be understood in the context of models with private information, limited communication, limited enforcement capabilities, transactions costs, and, and exogenously incomplete markets. The investigators also seek to measure using the standards suggested by these models the welfare impact of these informal and formal organizations, and their evolution in the context of the larger national economy. In this project, the investigators seek to understand the test various hypotheses, e.g., with the rise of formal substitutes over the long term, the informal sector may be less essential, especially in developed regions, or, alternatively, the informal sector may continue to play a crucial role as a more flexible and find-tuned complement to formal sector insurance and credit, especially in times of severe stress. To support our theoretical work, the investigators intend to field (only) two more rounds of the annual cross-sectional survey and to continue (on a reduced scale) the ongoing monthly survey, in order to ensure sufficient data for statistical significance of the various tests and to see the Thai economy on into the period of recovery and resumed (high) growth. The project data and other data would be organized in an innovative web-based archive for public release.